Enhancing Prolonged Exposure Therapy for PTSD with Oxytocin

Posttraumatic stress disorder (PTSD) is the most highly prevalent mental health disorder among U.S.
military Veterans. PTSD is a chronic disorder that is associated with significant morbidity, mortality,
disability, and costly health care expenditures. The clinical impairment associated with PTSD among Veterans
is severe and associated with comorbid depression, suicidality, substance abuse, physical health
problems, interpersonal violence, and neuropsychiatric impairment. Despite these pervasive health
consequences, the current treatment services offered to Veterans do not adequately address PTSD.
Several promising psychosocial interventions, including Prolonged Exposure (PE) therapy, have been
developed for the treatment of PTSD. Although PE is one of the most widely used evidence-based
treatments for PTSD, there is substantial room for improvement in outcomes and retention rates. For example,
approximately one-third of patients dropout of PE treatment prematurely, and the highest dropout rates occur
among Veterans. Consistent with the VA Office of Research and Development initiative to develop effective
treatments for PTSD, identifying pharmacotherapies to enhance PTSD treatment retention and outcomes is
critical. Accumulating data from our group and others suggests that oxytocin is a promising candidate to
achieve this goal. Oxytocin is known to promote prosocial behaviors associated with successful
psychosocial treatment outcomes (e.g., trust, safety, social cognition) and has demonstrated positive effects
on extinction learning in animal and human stress models. Furthermore, recent neuroimaging studies show
that oxytocin has the ability to ameliorate dysregulation of the corticolimbic brain circuitry, which is a central
component of the pathophysiology and maintenance of PTSD. In the only study to date examining the
feasibility, acceptability, and preliminary efficacy of augmenting PE with oxytocin, our group found that
participants randomized to the oxytocin condition demonstrated lower PTSD and depression symptoms
during PE, and had higher working alliance scores compared to participants randomized to the placebo
condition. Therefore, the primary objective of the proposed two-site Phase II study is to examine the ability of
oxytocin (vs. placebo) combined with PE therapy to (1) reduce PTSD symptom severity, (2) improve
rate of PTSD symptom improvement, and (3) improve PE adherence and retention rates. To
accomplish these objectives, we will employ a randomized, double-blind, placebo-controlled trial and use
standardized, repeated dependent measures of change at five time points (baseline, mid-treatment, end of
treatment, and 3 and 6 month follow-up). The proposed study directly addresses the mission of the Veterans
Health Administration Blueprint for Excellence in that it seeks to advance personalized and proactive mental
health care opportunities for Veterans. Findings from this study will provide critical new information regarding
the efficacy of oxytocin to augment psychosocial treatment for PTSD, as well as information regarding the
neurobiological mechanisms underlying PTSD and positive treatment response.

Public health relevance
Posttraumatic stress disorder (PTSD) is a chronic, debilitating condition that disproportionately affects Veterans. Prolonged Exposure (PE) therapy is a “gold standard” treatment for PTSD. However, approximately one-third of Veterans fail to receive an adequate dose of treatment because they prematurely drop out of PE therapy. There is also room to improve PE treatment outcomes. Consistent with the VA Office of Research and Development initiative to develop effective treatments for PTSD, the proposed randomized clinical trial will examine the ability of oxytocin (as compared with placebo) combined with PE to reduce PTSD symptom severity, improve the rate of PTSD symptom reduction, and to enhance PE treatment retention and adherence. This two-site study will leverage the investments made in the nationwide rollout off PE therapy and has the potential to significantly improve mental health care among Veterans, advance the science in this area, and identify mechanisms underlying positive PTSD treatment response.